Gene Regulation: From Mechanisms to Disease

ABSTRACT Support is requested for a Keystone Symposia conference entitled Gene Regulation: From Mechanisms to Disease, organized by Drs. Karen Adelman and Patrick Cramer. The conference will be held in Keystone, Colorado from January 26-30, 2020. Organismal development, homeostasis and healthy aging all rely on precise control of gene expression programs. Recent technological advances in structural biology, real-time imaging, and next generation sequencing have shed new light on decades-old questions about gene regulation, and we seek to highlight these advances. This meeting aims to bring together pioneers in cryoEM, single-cell microscopy, single cell sequencing and three-dimensional genome architecture, with leading experts in transcriptional regulation, to seed new collaborations and discoveries. This conference provides an ideal environment to foster interactions between transcriptional biologists and experts in single cell imaging and genomic approaches and spur conversations about how to interweave new techniques for structural biology with our growing appreciation that many critical interactions involve intrinsically disordered domains (which are by definition not well behaved in most structural approaches). Participants will attend sessions that critically evaluate the impact of genome organization on gene expression. The conference will also expose trainees to the best science possible and instill in them the enthusiasm we feel for the future of the field. Finally, pairing of this meeting with Cancer Epigenetics is ideal as the topics are inherently related. This allows our meeting to focus on underlying mechanisms and normal developmental systems, while enabling the audience to attend lectures in gene dysregulation in cancer. We plan two joint sessions to maximize interactions.

Public health relevance
PROJECT NARRATIVE The dysregulation of cell-type specific gene expression profiles, including the inappropriate activation/inactivation of specific genes, underlies many disease states, comprising the majority of developmental disorders and cancers. This conference will bring together pioneers in cryoEM, single-cell microscopy, single cell sequencing and three-dimensional genome architecture, with leading experts in transcriptional regulation, to seed new collaborations and discoveries. Pairing of this conference with Cancer Epigenetics is an ideal opportunity as the topics are inherently related, thus allowing our conference to focus on underlying mechanisms and normal developmental systems, while enabling the audience to attend lectures in gene dysregulation in cancer.